DCR Extramural Severable funding of core clinical research infrastructure in support of Ebola and other EID research.

This funding supports core clinical research infrastructure to facilitate a broad array of clinical trials on emerging and re-emerging infectious diseases, including Ebola, HIV, tuberculosis, febrile illnesses, influenza, and Zika.